Genetic and Epigenetic Determinants of Centromere Identity

Project Summary
The centromere is an essential chromosomal region that mediates kinetochore assembly and ensures
accurate chromosome segregation during mitosis and meiosis. Each chromosome must contain a single
centromere to prevent aneuploidy, chromosome breakage, and genome rearrangements– conditions
associated with tumors, developmental abnormalities, and infertility in humans. The mechanisms determining
how a specific chromosomal region is designated as the centromere (centromere identity) remain unclear. Our
laboratory investigates this question using Drosophila, a model with unmatched genetic tools and the unique
advantage of enabling centromere studies in the context of the organism. In complex eukaryotes, centromeres
are typically composed of highly repetitive DNA packaged into a unique type of chromatin containing the
histone variant CENP-A. Yet, how centromeric DNA and CENP-A chromatin specifically contribute to
centromere identity is not well understood. Our recent assembly and annotation of all Drosophila centromeres
revealed that CENP-A occupies islands of complex DNA enriched in retroelements, flanked by large blocks of
satellite DNA. Retroelements are frequently found within centromeres across taxa, but the significance of their
continued presence at these sites is unclear. We hypothesize that retroelements aid in maintaining centromere
integrity and function by facilitating centromere transcription, a process known to promote CENP-A assembly.
Simultaneously, retroelements exploit the low recombination rates and high tolerance for sequence variation
typical of these regions to further their own propagation. Using advanced techniques in genome editing, cell
biology, and genomics, this project will investigate the role of transcription in centromere identity, explore why
retroelements persist at centromeres through evolution, and determine how different centromeric DNA
sequences contribute to centromere transmission. Given that the basic centromere processes are conserved,
insights from this research are expected to advance our understanding of chromosome transmission and
centromere evolution mechanisms in other organisms, including humans.

Public health relevance
Project Narrative Accurate chromosome segregation during cell division relies on essential chromosomal structures called centromeres. However, the mechanisms by which a specific region is identified as the centromere are not well understood. Using advanced imaging, genome editing, and sequencing techniques in Drosophila, this proposal will test models of centromere specification, focusing primarily on the roles of centromeric DNA, its transcription, and centromeric chromatin.